Maintenance rTMS for depression (Maitr-De)

Abstract
Repetitive transcranial magnetic stimulation (rTMS) has emerged as a promising intervention for treatment-
resistant depression (TRD), yet substantial uncertainties persist regarding its efficacy as a maintenance
treatment. This prospective study seeks to investigate the efficacy of maintenance rTMS in individuals with TRD
who have previously responded to an acute course of rTMS. In the R61 phase of the study, we will recruit 75
participants across three study sites, the University of California San Diego, Cornell University, and Australian
National University, into a double-blind, three-arm maintenance treatment trial. In this trial, participants will be
randomized to receive either standard maintenance rTMS, clustered maintenance rTMS, or sham maintenance
rTMS for a duration of 6 months. Our primary aim is to examine the efficacy of maintenance rTMS on sustaining
connectivity between the dorsolateral prefrontal cortex (DLPFC) and subgenual cingulate cortex (SGC)
measured through concurrent TMS and electroencephalography (TMS-EEG) at baseline and every six weeks
throughout the 6-month treatment period. We will also assess changes in depressive symptom severity using
clinical scales including the Montgomery-Asberg Depression Rating Scale (MADRS) as a secondary outcome
measure. It is hypothesized that stimulation with clustered maintenance rTMS will demonstrate superiority in
sustaining DLPFC-SGC connectivity compared with standard maintenance rTMS and sham maintenance rTMS.
In the R33 phase, we propose to conduct a randomized 2-arm double-blind, parallel clinical trial comparing the
superior arm of the R61 phase with sham maintenance rTMS in 144 patients with TRD who have responded to
an acute course of rTMS treatment. The primary outcome of interest for this phase will be clinical symptom
maintenance measured with the MADRS, with the expectation that the active arm will lead to significantly better
sustained symptom relief than sham. As a secondary analyses, DLPFC-SGC connectivity derived through TMS-
EEG will be evaluated to compare between treatment arms and correlate with symptom change. It is anticipated
that active maintenance rTMS will lead to more sustained DLPFC-SGC connectivity than sham and that
connectivity will correlate with symptoms, providing a biomarker of treatment response that can potentially be
used for prescriptive selection of patients for maintenance treatment and as a measure of neuroplasticity for
continued scientific discovery. The overall goal of this research is to determine the most effective form of
maintenance rTMS treatment for patients with TRD and to understand the neurobiological underpinning of
maintenance rTMS treatment response.

Public health relevance
Narrative Treatment-resistant depression (TRD) patients who have responded to an acute course of rTMS are at high risk of symptom relapse and are frequently in need maintenance rTMS treatment. This R61/33 application aims to test dorsolateral prefrontal cortex – subgenual cingulate cortex (DLPFC-SGC) connectivity as a biological target of maintenance repetitive TMS (rTMS) treatment in TRD. In the 2-year R61 phase, we will enroll 75 participants diagnosed with TRD, who have responded to acute rTMS treatment, into a three-arm trial comparing standard and clustered maintenance rTMS to placebo stimulation, under the hypothesis that clustered maintenance will better sustain DLPFC-SGC connectivity. In R33 phase, we will evaluate clinical efficacy and target engagement in 144 patients divided equally between active and placebo maintenance rTMS with the overall goal of determining the efficacy of maintenance rTMS and identifying the neurophysiological mechanisms underlying treatment response.